Psychiatric and substance use disorders in Puerto Rico before and after Hurricane Maria

PROJECT SUMMARY/ABSTRACT
In September 2017, Hurricane Maria hit the island of Puerto Rico and wreaked havoc throughout the island,
making it the most destructive storm in recorded history. The island's residents were still recovering from
Hurricane Irma, which hit two weeks prior. For months after Maria, many communities lacked essential
services and resources, such as access to electricity, potable water, safe roads and bridges, healthy foods,
and medical care. Indeed, eight months later there are still communities lacking these services and resources.
The extent of the damage, which impacted all residents regardless of geography or poverty status, and the
fragile state of the Puerto Rican economy led to an institutional recovery response that was unprecedentedly
slow and insufficient. The confluence of these factors created substantial population risk for psychiatric and
substance use problems, particularly among those with a history of psychopathology. Few studies have
examined the longitudinal development and exacerbation of psychiatric and substance use disorders before
and after a natural disaster using the same representative sample. We have the unique opportunity and
advantage of a preassembled cohort based on an island-wide representative sample stratified by the eight
health regions of Puerto Rico. The cohort, which consists of 3,062 Puerto Ricans, ages 18-64 years, was
surveyed from May 2014 to June 2016, one year before Maria hit the island. All lifetime and 12-month
psychiatric and substance use disorders were assessed in this cohort using the World Mental Health-
Composite International Diagnostic Interview (WMH-CIDI Version 21). We propose a second wave of
assessments with a focus on anxiety, trauma-related, depressive, and substance use disorders, and
suicidality. Using the National Institute of Minority Health and Health Disparities Research Framework and the
Resilience Activation Framework of Abramson and colleagues, we will address four specific aims: (1)
estimating the change in prevalence of psychiatric and substance use disorders from pre- to post-hurricane, (2)
understanding the mechanisms that lead to increased psychopathology, including institutional response and
recovery efforts and post-disaster stressors, (3) identifying the personal, family and neighborhood factors that
lead to resilience among those who did not have psychopathology post-Hurricane Maria, and (4)
understanding the effects of institutional response and recovery efforts on psychopathology across the eight
health regions that vary in geography and levels of hurricane impact. The project is innovative in providing
unique estimation of the longitudinal development and exacerbation of psychopathology pre- and post-
hurricane, and, in examining unique mediators, particularly institutional response and recovery failures. It is
also innovative in focusing on different levels (i.e.,personal, family, neighborhood) of factors that lead to
individual resilience in the face of a major natural catastrophe in an economically struggling territory.

Public health relevance
PROJECT NARRATIVE The entire island of Puerto Rico was devastated by Hurricane Maria and continues to struggle with recovery efforts. This study will take advantage of an island-wide representative cohort that was surveyed for psychiatric and substance use disorders one year before the hurricane hit and will examine the risk for psychopathology post-disaster. Our study will test unique questions regarding the relationships among personal, family and neighborhood hurricane stressors, institutional response and recovery efforts, and resiliency in predicting the development and exacerbation of mental health problems after an unprecedented natural catastrophe in an all minority US territory.